MINDBP - Mindfulness and Wearable Biosensors to Prevent Hypertensive Disorders of Pregnancy

PROJECT SUMMARY/ABSTRACT
Hypertensive disorders of pregnancy (HDP) are the most common medical condition affecting pregnancy and a
leading cause of maternal morbidity and mortality in the United States. HDP increase lifetime cardiac disease
risk in women and infants exposed during pregnancy and are considered an independent cardiovascular risk
factor by the American Heart Association. Consequences of HDP extend well past the perinatal period; women
with HDP are twice as likely to develop heart disease in their lifetime, and offspring exposed to HDP in utero
face significant lifetime cardiovascular disease risk. Importantly, HDP are driving an increase in other adverse
pregnancy outcomes and increasing costs of care. Current prevention strategies are limited and only partially
effective. Mindfulness-based interventions hold significant promise as a non-pharmacological intervention to
prevent HDP. Mindfulness-based interventions significantly reduce blood pressure in adults with hypertension
and prehypertension. In single-site studies, our team has demonstrated that prenatal phone-delivered
mindfulness training (MT) intervention is feasible and acceptable, shows high participant retention and protocol
adherence, and demonstrates reductions in prenatal blood pressure and recurrence of HDP. Now, we seek to
determine if prenatal MT intervention can be feasible, acceptable, and delivered with fidelity across multiple
sites. In addition, we will explore whether our intervention can have even higher adherence with minor
enhancement using wearable biosensors as they hold great potential to augment the beneficial effects of MT
by enabling continuous, real-time, and non-invasive monitoring of physiological responses. Therefore,
consistent with the limited competition notice of funding opportunity (RFA-AT-25-002), the goal of this multi-site
clinical trial, titled: “Mindfulness and Wearable Biosensors to Prevent Hypertensive Disorders of Pregnancy -
MINDBP” is to test a 16-week (8 weekly session plus two monthly booster sessions), three-arm, non-
pharmacological intervention that includes MT and wearable biosensor feedback among 90 pregnant women
at high risk for HDP. In Aim 1 we will assess feasibility and fidelity of MINDBP delivery across sites. In Aim 2
we will evaluate the acceptability of MINDBP by assessing participants’ satisfaction, engagement, and
perceived usefulness of the intervention (Aim 2). In Aim 3 we will finalize components of MINDBP for future
trial by examining change in psychological and physiological response (blood pressure, heart rate variability,
perceived stress, and pregnancy-specific anxiety) within each study arm. The MINDBP study will generate
necessary data to inform a future large-scale trial examining effectiveness of MT in HDP prevention. Data
collected under this R01 will fill important gaps in scientific knowledge necessary and sufficient to establish
operational feasibility and design of the larger multisite trial that will generate evidence to guide scalable
complementary and integrative HDP prevention strategies.

Public health relevance
NARRATIVE Hypertensive disorders of pregnancy (HDP) are a leading cause of maternal and neonatal morbidity and mortality in the U.S. The goal of this trial is to test multisite feasibility, acceptability, and fidelity of a prenatal mindfulness training intervention to inform a future fully powered effectiveness trial designed to prevent HDP.